PRISM

Project Summary / Abstract
Bronchopulmonary dysplasia (BPD) is the most common respiratory sequelae of prematurity and is often fatal.
Montelukast is FDA-approved and already shows promise in small neonatal trials. Because of limited
pharmacokinetic (PK)/pharmacodynamics (PD) research, the optimal montelukast dose for premature infants
to avoid BPD is unknown. We propose the Pharmacokinetic and pharmacodynamic study of montelukast in
infants with developing BPD (PRISM) trial, a dose-escalating open-label pharmacokinetic, safety and
preliminary efficacy trial in premature infants (born < 29 weeks’ gestation) at high risk for BPD (requiring
positive pressure ventilation between 29-33 weeks). Our central premise is that re-purposing a non-steroid
anti-inflammatory agent will be safe and show preliminary efficacy in preventing BPD. Our objective is to
perform population-specific PK/PD analyses under FDA regulatory guidance to identify the optimal montelukast
dose to use in a definitive phase III trial. The trial will begin with a low-dose (0.75 mg/kg/day) cohort, and will
proceed sequentially to the medium- (1.5 mg/kg/day) and high-dose (2.25 mg/kg/day) cohorts after safety
reviews. Dosing will last 4 weeks involving 90 infants (30/cohort) at up to 8 experienced neonatal sites. A
comparator cohort of placebo-treated NICHD-trial infants with similar age and disease severity will serve as
historical controls. The primary outcome will be the drug clearance (CL/F), which is the key determinant of
maintenance dosing. Secondary outcomes will include safety (determined by total adverse events) and
exposure-response relationships between montelukast and change in BPD risk over the treatment period.
Our first aim will be to characterize the PK of montelukast in premature infants. We hypothesize that the
clearance in the infants ≤ 28 weeks post-menstrual age (PMA) (i.e. PMA = gestational age + postnatal age) will
be at least 30% reduced compared to infants > 28 weeks. Our second aim is to characterize the safety profile
of montelukast in premature infants; we hypothesize that the montelukast adverse event rate will not increase
with montelukast exposure. Lastly, we aim to determine preliminary efficacy of montelukast in premature
infants; we hypothesize that the change in moderate-severe BPD risk calculated from a population PK/PD
linear regression model will decrease by 30% with increasing montelukast AUC0-24.The PRISM PK/PD results
will be submitted to the FDA, and will help determine the optimal dose of montelukast to reduce BPD. The
impact of the PRISM trial could be monumental in the field of neonatology.

Public health relevance
Project Narrative Bronchopulmonary dysplasia (BPD) is the most common respiratory sequelae of prematurity and is often fatal. While very few treatment options exist that safely reduce BPD, montelukast is FDA-approved and already shows promise in small neonatal trials. Because of limited pharmacokinetic (PK)/pharmacodynamics (PD) research, the optimal montelukast dose for premature infants to avoid BPD is unknown; leveraging an experienced team, the PRISM PK/PD trial will determine the optimal dose of montelukast to reduce BPD.